Development and Evaluation of Portable Compendium of Psychophysical and Physiological Tests for Alzheimer's Disease and Related Dementias (ADRD)

ABSTRACT
The Development and Evaluation of Portable Compendium of Psychophysical and Physiological Tests for
Alzheimer’s Disease and Related Dementias (ADRD) is a project to develop an inexpensive, user-friendly,
digital chemosensory-sensorimotor acquisition and processing device, with cross-cultural validity for home or
office use for automated (a) staging of severity of age-related cognitive decline, (b) prognostication of people
with subjective cognitive impairment at risk for progressive neurodegenerative diseases, and (c) remote
surveillance of trajectory in motor and chemosensory markers of ADRD progression in elderly populations.
Given that some decline in cognition is expected with advancing age, it is very challenging for elderly people to
determine if their cognitive challenges are normal for age, or pathological. Similarly, our stakeholder survey of
physicians who treat geriatric populations revealed that <10% of these physicians expressed self-efficacy in
identifying early pathological cognitive decline in elderly patients complaining of subjective memory concerns,
whereas more than 95% feel comfortable with diagnosing moderate or severe dementia. This is problematic,
because, following onset of defining symptoms of dementia, ADRD progresses relentlessly, and no
intervention has proven to reverse, or even slow the progression of dementia; whereas early identification may
offer a more realistic opportunity for disease-modifying interventions to slow AD progression. Science has
shown that AD presents early (even preclinically) with motor and sensory impairments, particularly olfactory
dysfunctions. Therefore, an alternative approach to classification and prognostication of AD is to use precise
quantitative measurements of sensory and/or motor dysfunctions. Indeed, psychophysical tasks of olfaction,
such as odor identification tasks, have been found to predict AD development in normal aging, and to predict
AD progression in mild cognitive impairments (MCI). But these olfactory cognitive tasks have not been adopted
in practice or research for AD classification because of low specificity, challenges with interpretation,
susceptibility to education, culture, and language biases, and absence of defined cut-off scores for classifying
normal cognitive aging from MCI, or for prediction of MCIs who would soon develop dementia. Evon Medics, a
small business specializing in olfactory neurostimulation, tested various olfactory tasks in their prototype – the
Evon Medics Rapid Smell Test (EMRAST) – and determined that an olfactory sensorimotor impairment marked
by loss of reflex reduction of sniff magnitudes to intense or unpleasant odorants, differentiated progressive MCI
from normal cognitive aging, and quantitatively predicted MCI subjects that transitioned to dementia over 6-
month follow-up. The goal of this SBIR Fast-Track proposal is to refine and evaluate composite scores derived
from an extended portable version of EMRAST with psychophysical and physiological tasks of olfaction and
measures of motor and sensorimotor functions, for prediction of ADRD among elderly people with memory
concerns, prognostication of incipient dementia among people with MCI, and for remote monitoring of ADRD,
which is a reimbursable service and a powerful incentive for adoption by health providers. The remote
monitoring component also alleviates anxieties of family members of elderly persons who live independently.
In the Phase I, we will (1) integrate all physiological sensors for olfactory sensorimotor and finger movements
into the EMRAST prototype; (2) conduct a pilot testing on normal aging, MCI and early dementia patient
populations for development of classification and prediction functions and algorithms; (3) integrate the Evon
Medics HIPAA-compliant mobile App and cloud infrastructure into the product to enable seamless
communication of data from the device to the user’s physician for remote monitoring of AD and modifiable
health determinants of AD; and (4) examine fidelity of use and user/provider satisfaction. In Phase II, we will
conduct large clinical validation testing to fine-tune the classification algorithms derived from Phase I. This will
lead to automated interpretation, which the physicians desire. We will also advance regulatory pathway to
clinical practice and establish the cost-effectiveness of use of EMRAST-Extended for remote monitoring of
ADRD and associated comorbidities. Project success will be enhanced through strong collaborations between
Evon Medics, Howard University and Johns Hopkins University investigators and AD stakeholders. The
investigative team has significant experience in product and business development, ADRD clinical research,
public health, and development and evaluation of olfactory devices. Completion of grant activities will lead to
an optimized product to allow (1) clinical screening for early detection and prognostication of progressive
neurodegenerative disease in people presenting with subjective cognitive complaints or age-associated
memory complaints, (2) prediction of incipient dementia in people with mild cognitive impairment, and (3) broad
international use as a language- and culture-independent tool for ADRD diagnosis and research.

Public health relevance
NARRATIVE Longstanding neuroscience evidence is consistent that olfactory, other sensory, sensorimotor, and motor impairments often precede cognitive impairments in AD, thereby presenting an alternative strategy for detection of people at risk of progressive cognitive decline. The small business, Evon Medics created a prototype called EMRAST (Evon Medics Rapid Smell Test for AD), to perform culture- and language- independent smell tests for AD screening. This project will further product development to allow the: (1) incorporation of physiological monitoring and motor processing sensors and a sniff magnitude test, which we recently showed to signal an irreversible phase of AD progression when impaired; (2) development of machine learning/Artificial Intelligence algorithms to compute the EMRAST metrics into prediction of AD; (3) optimization of size, cost reductions, test functionality, durability, and hardware complexity for large-scale manufacturing; (4) demonstration of clinical validity in large samples; and (5) advancement of regulatory pathway to lead to adoption of optimized EMRAST (i.e., EMRAST-Extended) for clinical and community screening and prediction of AD progression.